Epigenetic Regulation of Retinal Development by BCOR

Project Summary
Normal vision depends on the balanced generation and homeostatic regulation of major retinal cell types, and
the disruption of these processes may result in congenital retinal disorders and retinal degeneration, affecting
millions of people around the world each year. Regenerative medicine depends on our understanding of retinal
development for informing retinal cell reprogramming and manufacturing. While there have been significant
advances in unravelling the roles of transcription factors, a major gap exists in our knowledge of how these
tightly regulated gene networks are governed by epigenetic mechanisms. Polycomb-group complexes are
evolutionarily conserved epigenetic machineries that remodel chromatin through histone modifications for
silencing targeted genes and have been recently shown to affect retinal neurogenesis and lineage decisions.
BCOR is a component of the Polycomb Repressive Complex 1 variant that ubiquitinates lysine 119 on histone
H2A (H2AK119Ub). Dysregulation of BCOR is clearly associated with eye and retinal disorders, including Lenz
microphthalmia, Oculofaciocardiodental Syndrome, and retinoblastoma, but its role in retinal neurogenesis is
still not well understood. In preliminary studies, I performed coimmunoprecipitation-mass spectrometry and
validated BCOR’s interaction with other PcG proteins in retinal cells. I then performed BCOR chromatin
immunoprecipitation sequencing (ChIP-seq) and identified strong peaks at retinal progenitor genes LHX2,
PAX6, SIX3, and SIX6, all of which are significant in optic vesicle development and later play distinct roles in
retinal cell fate decisions. Thus, I propose to investigate the role of BCOR in retinal neurogenesis. I
hypothesize that BCOR mediates the switch from retinal progenitors to differentiated cell types by recruiting
PcG proteins to regulate H2AK119Ub on the chromatin to repress multipotency genes. I will test this
hypothesis with the following aims: (1) Identify the epigenetic mechanism of BCOR for regulating retinal
progenitor genes, and (2) Determine how BCOR affects the generation of major retinal cell types in vivo. My
overall objective is to characterize BCOR-ncPRC1.1’s role in retinal development as an avenue to discovering
new epigenetic targets for regenerative strategies in the retina.

Public health relevance
Project Narrative Regenerative medicine in the retina is an attractive solution for improving quality of life in patients affected by neurodegenerative diseases and depends on our knowledge of retinal development. Polycomb-group (PcG) complexes are evolutionarily conserved, powerful epigenetic machineries that regulate cell-fate decisions, and here, we identified retinal multipotency genes as novel targets of the PcG protein BCOR. Decoding how BCOR epigenetically regulates retinal neurogenesis may have wide implications for new targets in regenerative strategies.